Computational analysis of complex genetic interactions

Project Summary / Abstract
How does the DNA sequence of an organism (genotype) determine its form and function (phenotype)?
New technologies such as massively parallel reporter assays (MPRAs), deep mutational scanning, and
combinatorial CRISPR screens have the potential to expose the genotype-phenotype relationship at an
unprecedented level of detail by measuring phenotypes for tens of thousands to millions of genotypes in a single
experiment. However, interpreting the results of these experiments is difficult because the space of genotypes
is intrinsically high-dimensional and combinations of mutations often interact in complicated ways. My research
program is focused on developing new computational tools to analyze data from these high-throughput
experiments, with the goals of (1) identifying the major qualitative features of the genotype-phenotype
relationship in specific biological systems, (2) explaining how these qualitative features arise from underlying
developmental, cell biological and biophysical mechanisms, (3) being able to accurately predict the phenotypes
of unmeasured genotypes, and (4) quantifying the uncertainty in these predictions.
During the previous funding period, our group developed a suite of new computational techniques for
inferring the structure of genotype-phenotype relationships, where these techniques are based around a class
of highly flexible statistical models known as Gaussian processes that we have customized for use in analyzing
high-throughput combinatorial mutagenesis experiments. While these methods have been very successful at
analyzing complex genetic interactions, they are still currently limited to the analysis of relatively short
sequences. Here we propose to scale these methods up to work on whole proteins or even genome-wide by
leveraging recent breakthroughs in the ability of GPUs to accelerate Gaussian process based inference. At the
same time, we will develop two new Gaussian process based techniques, one that extends our existing methods
to address diploid genotypes, and one that can better infer and then exploit knowledge of which sites and
mutations in a functional genetic element are most important.
Expressive computational modeling and high-throughput measurements have the potential to transform
molecular biology by allowing accurate prediction of the effects of mutations, both singly and in combination.
Important applications include mapping adaptive paths to immune escape and drug resistance variants in
infectious disease and cancer, designing improved antibodies and enzymes, and genomic variant interpretation.
Development of the computational tools proposed here will further these goals by providing a principled, practical
framework for understanding the complex genetic interactions revealed in contemporary high-throughput
experiments.

Public health relevance
Project Narrative Mutations often interact with each other, so that knowing the effects of individual mutations is not enough to predict how they will combine. This unpredictability makes it difficult to prevent the emergence of antibiotic resistance and immune evasion in infectious disease, complicates efforts to assess the pathogenicity of variants in human genome sequences, and hampers our ability to develop new protein-based therapeutics, antibodies, and enzymes. This project will improve our ability to predict how mutations interact by developing new computational tools to model the combined impact of multiple mutations based on data from large sequence databases and high-throughput experiments.